A randomized controlled trial of a novel, evidence-based algorithm for managing lower respiratory tract infection in a resource-limited setting

Project Summary/ Abstract
Lower respiratory tract infection (LRTI) is one of the most common reasons for hospitalization globally. Viral
and bacterial LRTI present similarly, leading clinicians to overprescribe antibacterials for fear of missing a
lethal bacterial infection or superinfection. However, emerging data from global cohorts indicate that viral LRTI
is frequently more prevalent than bacterial LRTI in both children and adults. In low- or middle-income countries
(LMICs), antibacterial overuse for viral LRTI is often worse given limited diagnostic capacity. Access to point-
of-care (POC) diagnostic tests, which do not require laboratory infrastructure, may decrease antibacterial
overuse for LRTI in LMICs. Locally relevant, evidence-based, cost-effective diagnostic algorithms for LRTI
have not been systematically developed in LMICs. The objective of this proposal is to integrate multiple low-
cost diagnostic tools (clinical predictors, POC pathogen tests, and POC biomarker tests) to develop and
evaluate an LRTI diagnostic and treatment algorithm in a LMIC setting. We will use a large, existing, setting-
specific biorepository of patients with LRTI to guide algorithm development. The following aims are proposed:
1) create an evidence-based algorithm for LRTI management by integrating clinical predictors, POC pathogen
tests, and POC biomarker tests; 2) establish understanding, acceptability, and barriers to implementation of
clinical algorithms for LRTI management among local physicians; and 3) evaluate an LRTI management
algorithm in a stepped-wedge, cluster randomized trial at a single hospital in a LMIC. We will complete gold-
standard testing and clinical adjudications of samples in our biorepository to identify etiology of infection. We
will then construct decision trees by inputting 1) clinical predictors, 2) POC pathogen tests, and 3) POC
biomarker tests to identify a potentially cost-effective algorithm that would reduce inappropriate antibacterial
prescriptions. We will conduct focus group discussions with local physicians to identify barriers and facilitators
to using clinical algorithms. Following algorithm development, we will reconvene focus groups to iterate on the
algorithm and to determine appropriate methods for communicating and implementing the algorithm. We will
then conduct a stepped-wedge cluster randomized trial to evaluate the algorithm. Patients admitted with LRTI
will receive either 1) algorithm-directed care, or 2) usual care. To assess clinical outcomes and antibacterial
duration concurrently in this trial, we will use the innovative Response Adjusted for Duration of Antibiotic Risk
(RADAR) clinical trial design developed by the Antibacterial Resistance Leadership Group (ARLG). The
expected outcome of this work is the development and evaluation of a LRTI diagnostic algorithm that uses
local evidence and integrates multiple low-cost diagnostic tools. The long-term goal of this work is to translate
these methods to other low-resource settings to combat the growing global crisis of antimicrobial resistance.

Public health relevance
Project Narrative Lower respiratory tract infection (LRTI) is a common reason for antibacterial use and overuse globally. The objective of this proposal is to develop and evaluate an evidence-based, cost-effective strategy to improve antibacterial use for LRTI in a low-resource setting. The long-term goal of this work is to translate these methods to other low-resource settings to combat the growing global crisis of antimicrobial resistance.